IDENTIFICATION OF PATIENTS WITH PREDIABETES

This study will attempt to identify prediabetes in close family members of Type I diabetics by using screening for islet cell antibodies and diminution of insulin production during IV glucose tolerance.